Role of PTSD associated gut dysbiosis and barrier dysfunctions in promoting IBD in Veterans

This Collaborative VA Merit application (CMA) is being submitted as part of a group of 5-linked CMAs from
nationwide VA experts in gastrointestinal (GI) and liver diseases, who have formed a national steering committee
after participating in a successful field-based meeting in San Diego in May 2019 (funded by VA ORD). The
roadmap developed at this meeting was published in Gastroenterology (1). Specifically, this proposal is part of
a cluster of CMAs that are aimed at advancing our knowledge about the emerging role of gut microbiome for a
better understanding of the pathophysiology of Veterans service and deployment related GI and liver diseases
including the more prevalent disorders associated with the GWI and PTSD, and to develop potential
biotherapeutics to alleviate the disease symptoms. In this regard, the importance of an altered diversity of the
gut microbiome in the development and progression of gastrointestinal diseases including inflammatory bowel
disease (IBD) is supported by a range of evidence including patient-based studies and mouse modelling of the
disease. The overall incidence of IBD among Veterans has increased 2-3 folds however the underlying
mechanism(s) are unclear. The Veterans’ health care system has noticed a similar rise in the cases of the PTSD
and GWI. An association of the altered gut microbiota has also been reported in the Veterans suffering from
PTSD and GWI. However, there are no systematic studies focusing on the role of the gut microbiome in service
and deployment-related increases in IBD risk in the Veterans. Our hypothesis in this CMA is that, in Veterans,
PTSD-associated gut microbiota synergizes with gut barrier dysfunctions to promote risk for IBD and/or disease
severity. A collaborative approach using the gut microbiome from Veterans with PTSD, metagenomics, and
state-of-the-art mouse models and technologies will be employed to test this hypothesis in following proposed
studies: Aim-1. To examine whether PTSD-associated Gut dysbiosis in a humanized mouse model promotes
susceptibility to colitis and/or disease severity; Aim-2. To investigate if mouse models mimicking barrier protein
defects, as seen in preliminary data, are at higher risk of developing PTSD & associated risk of colitis, and possible
mechanisms; and Aim-3. To determine the causal link between PTSD-associated gut microbiota and mucosal
injury/repair in specific contexts of epithelial intrinsic and in vivo settings of colitis. Specific role of gut barrier
proteins will be examined in ‘pore’ and ‘leak’ pathways and colitis associated injury/repair. The outcome from
proposed studies should help establish the causal relationship between PTSD-associated microbiome and an
increased risk for IBD in Veterans and thus may aid in development of novel strategies in mitigating such risk.

Public health relevance
Inflammatory bowel disease (IBD) is a conglomerate of debilitating auto-immune disorders of the gastrointestinal tract, which significantly affect one’s lifestyle including active-duty army personnel and the Veterans. Studies for the Department of Veterans Affairs however found that the incidence of IBD among Veterans has recently increased 2-3 folds. An improved understanding of the causal regulation of this increase in IBD in Veterans can open novel therapeutic opportunities. In this proposal, we will perform “Proof-of-Concept” and mechanistic research to understand the causal role of Gut Microbiota associated with Post-Traumatic Stress Disorder (PTSD) in the Veterans in promoting IBD risk and severity. Critical concepts that will be evaluated include whether PTSD- associated Gut Dysbiosis promotes IBD risk by synergizing with gut barrier dysfunctions. Anticipated outcome from the proposed studies will have significant impact upon the clinical management of IBD, the quality of life of the Veterans IBD patients, and in reducing the economic burden of the VA-hospital system.